Targeting Metabolic Vulnerabilities of Triple Negative Breast Cancer Stem Cells

PROJECT SUMMARY/ABSTRACT
Triple negative breast cancer (TNBC) is the most aggressive subtype with increased propensity for metastasis
and few treatment options. Mounting evidence suggests that cancer stem-like cells (CSCs) in TNBC contribute
to the early recurrence and poor clinical outcomes. Thus, identification of novel therapeutic approaches
effectively targeting CSCs is crucial for improving outcome in TNBC. We propose to target CSCs in TNBC by
exploiting their overexpression of two redox regulating enzymes, NQO1 and SOD1 as a therapeutic vulnerability.
Utilizing a potent NQO1-bioactivatable redox cycling compound, IB-DNQ, which generates large amounts of
reactive oxygen species in CSCs via futile redox cycling, we propose to examine the feasibility of utilizing IB-
DNQ alone, or in combination with SOD1 inhibition, to effectively target CSCs across the EMT-MET CSC state
continuum. We will address three specific aims: 1) To demonstrate the efficacy of IB-DNQ alone or in
combination with SOD1 inhibition in targeting CSCs in vitro and in mouse models of human TNBC; 2) To
determine the mechanisms of cell death induced by IB-DNQ based pro-oxidant strategies; and 3) To determine
how IB-DNQ based pro-oxidant strategies modulate antitumor immunity in immunocompetent mouse models.
This proposal will evaluate a novel pro-oxidant-based approach in selectively targeting CSCs in TNBC and
elucidate the mechanism of action for futile oxidant generators in activating mitochondrial apoptotic and
pyroptotic cell death with resultant stimulation of antitumor immunity. As NQO1 and SOD1 are overexpressed
in many solid tumors, this therapeutic strategy may have wide applicability.

Public health relevance
Project Narrative Triple negative breast cancer (TNBC) is the most aggressive form of breast cancer associated with an increased proportion of cancer stem cells (CSCs). In this application, we utilize IB-DNQ, a futile redox cycling compound bioactivatable by NQO1 to generate large amounts of reactive oxygen species, an effect potentiated by SOD1 inhibition to target CSCs of TNBC. We will elucidate the mechanisms by which this pro-oxidant strategy induces apoptotic and pyroptotic cell death in CSCs, leading to enhanced host antitumor immunity. Since CSCs display resistance to conventional cancer treatments as well as to immunotherapy, this strategy has the potential to improve the outcome for women with this aggressive form of breast cancer.